Pacritinib in rel/refr T-cell lymphomas

PROJECT ABSTRACT
The T-cell lymphomas (TCL) are an area of unmet medical need as patients, particularly those with relapsed or
refractory disease, are rarely cured with existing therapies. We, and others, have shown that antigen-,
costimulation-, and cytokine-dependent signaling cooperatively promote the growth and survival of malignant T
cells and confers their resistance to conventional chemotherapy. These signaling cascades are propagated by
highly recurrent gain-of-function mutations in relevant kinases and by exogenous ligands provided by
constituents of the tumor microenvironment (TME), including lymphoma-associated macrophages (LAM). Early
phase clinical trials investigating tyrosine-kinase inhibitors (TKI) selective for relevant targets have been
completed (or are ongoing), but most responses observed with these agents are partial and rarely durable. The
genetic and molecular heterogeneity associated with the TCL and the cooperativity (and partial redundancies)
among signaling pathways may explain the suboptimal activity associated with many targeted agents.
Constituents of the TME, particularly LAM, create a niche that promotes TCL growth and survival both directly,
by providing exogenous ligands for TCL-associated antigen, costimulatory, and cytokine receptors, and
indirectly by suppressing host anti-tumor immunity. Therefore, an alternative, and potentially complementary,
therapeutic approach is to target LAM. Efforts to deplete tumor-associated macrophages have been largely
devoted to colony-stimulating factor-1 receptor (CSF-1R) antagonists, as current dogma suggests that this is
the dominant homeostatic cytokine required for the survival of tissue resident macrophages. However, our own
preliminary data challenges this conception, at least in a TCL context. Pexidartinib, for example, is a selective,
and FDA-approved, CSF-1R TKI, to which TCL-associated macrophages are largely resistant. As LAM play a
central role in TCL pathogenesis, one of our long-term goals is to develop novel, targeted therapies that impair
their expansion, survival, and functional polarization. With that goal in mind, we performed an unbiased, high-
throughput screen with almost 200 targeted agents, and discovered that TCL-associated macrophages, while
resistant to multiple selective CSF-1R antagonists, were highly sensitive to pacritinib. Pacritinib is a safe, well
tolerated, oral Janus family kinase (JAK) inhibitor that has been investigated in multiple phase I, II, and III
studies (largely in myeloproliferative neoplasms). In addition to inhibiting multiple JAKs (JAK2, TYK2, JAK3),
we have shown that pacritinib inhibits CSF-1R and Src family kinases at clinically achievable concentrations,
both of which are highly relevant targets in TCL. Therefore, our overarching premise, is that inhibition of
multiple, highly relevant kinases with both cell-autonomous and non-cell-autonomous roles in TCL
pathogenesis is an attractive, but largely unexplored, therapeutic strategy that warrants further investigation.
Our overall objectives in this application are to examine the efficacy of pacritinib and interrogate relevant
predictive and pharmacodynamics biomarkers in an investigator-initiated, multicenter, phase II clinical trial.

Public health relevance
PROJECT NARRATIVE Relapsed and refractory T-cell lymphomas (TCL) are associated with poor clinical outcomes. However, we have identified a multikinase inhibitor that is selective for multiple kinases that have important cell-autonomous and non-cell-autonomous roles in the T-cell lymphomas. Therefore, we will conduct an investigator-initiated, multicenter, phase II study with this agent in multiple cohorts of relapsed/refractory T-cell lymphomas.